Harmonizing Hospital-Based Violence Intervention Programs with a Novel Medical-Legal Partnership for Equity in the Social and Structural Determinants of Health – the HVIP-MLP Model

Project Abstract:
National trauma center verification relies on a commitment to injury prevention efforts, including against
community-level violence. Hospital-Based Violence Recovery Programs (HVIPs) have expanded across the
country as extensions of Level I and II trauma centers to address trauma recidivism with individual behavioral
modification during the “teachable moment”. There is no evidence to date that has demonstrated effectiveness
in this approach for HVIPs, despite proliferation across the country. A criticism of this approach to violence
prevention is the difficulty for community-based violence prevention specialists from HVIP programs to address
the larger inequities in the Structural and Social Determinants of Health (SSDOH) that lead to violence through
individual behavior modification. Medical-Legal Partnerships have been one approach that has demonstrated
evidence and success in improving health outcomes and reducing health-harming legal needs of patients, by
connecting legal experts to medical experts for holistic care. This has yet to be done for trauma patients and
has, to our knowledge, not been incorporated into any HVIP approach thus far, for a Medical-Legal Partnership
(MLP). In our biphasic proposal, our UG3 aims are to clearly identify the types of health-harming legal needs of
our patients and families affected by firearm violence and examine the population-level differences in types of
legal needs by sociodemographic and geographic factors. We them aim to develop the HVIP-MLP model for
implementation at our urban, Level I Trauma Center on the South Side of Chicago. Our UH3 aims would be to
then examine implementation outcomes (acceptability and feasibility) of our novel MLP compared to standard of
care with our HVIP. We would then examine health outcomes via a pragmatic clinical trial measuring primary
health outcomes (stress and health-related quality of life) and secondary, validated SSDOH outcomes
[improvements in income, housing & utilities, employment, legal needs and personal & family stability (I-HELP)].
As a developmental exploratory aim, we will also measure stress and health-related quality of life in our HVIP-
affiliated violence recovery specialists that engage their patients in the MLP model, as well access the
intervention themselves, as needed. Close coordination with the CLIP-VP Coordinating Center will be essential
specifically for data handling, measurement, analytics support and consultation with future public/stakeholder
engagement and dissemination to demonstrate our public health impact. This novel HVIP-MLP approach has
the potential to broadly impact the HVIP model to include an MLP component to all trauma centers for verification
to support patients, families and providers alike in this important public health work.

Public health relevance
Project Narrative: Hospital-Based Violence Intervention Programs (HVIPs) affiliated with trauma centers in the US focus on individual behavior modification for a reduction in re-victimization. There is a lack of reproducible evidence that has demonstrated effectiveness, given the exclusion of addressing inequities in the Social and Structural Determinants of Health (SSDOH), often the root cause of violent injury and preventable homicide. We propose the creation of a novel Medical-Legal Trauma Partnership to offer legal support to improve the SSDOH, reduce stress, improve the health-related quality of life in patients, families and HVIP providers alike while collaborating with the CLIF-VP Coordinating Center for broad trauma center distribution for public health impact.